Mayo Comprehensive Cancer Center Grant (MICEO Supp) - Impact of Multi-Channel Communication Campaigns on Cancer Prevention, Control and Survivorship (CaPCaS) in Black, Hispanic, and Rural Populations

ABSTRACT
This application is being submitted by the Mayo Clinic Comprehensive Cancer Center (MCCCC) in
response to the “Administrative Supplements for the NCI P30 Cancer Center Support Grants for Multi-Channel
Communication Campaigns”. The MCCCC community outreach and engagement activities are led by the
MCCCC Community Outreach & Engagement (COE) Office and Programs in three MCCCC catchment areas
(CAs), including Arizona (AZ), Florida (FL) and the Midwest/Mayo Clinic Health Systems (MCHS). Although our
3-site catchment areas (CAs) are unique communities, the top cancers at each site are lung, breast, prostate,
colorectal and pancreas. However, cancer disparities are uniquely different for the priority populations. In AZ
CA, the targeted cancers are colorectal cancer (CRC) and liver cancer. Hispanics are twice likely to die from
liver cancer compared to NH Whites. Although the CRC mortality rate is similar for both Hispanic and NH Whites,
the CRC mortality rate for AZ CA Hispanics is elevated compared to US Hispanics. In FL CA, the targeted cancer
is prostate cancer (CaP) in NH Black men. CaP leads cancer mortality among NH Blacks in the FL CA. Black
men are twice as likely to die from CaP. The CaP death rate for Black men in FL is also elevated compared to
the death rate for US Black men. In the Midwest/MCHS CA, the targeted cancers are lung, prostate, and
colorectal cancers. These cancers are three of the top five cancers in the CA.
The proposed supplement project focuses on Track 2, targeting the general population aged 30 years
and above. Multi-channel communication campaigns will be delivered by Community Health Educators (CHEs)
across the cancer care continuum and tailored to each of the MCCCC CAs. The primary goal of the supplement
is to assess the impact of multi-channel communication campaigns targeting Black, Hispanic, and Rural
populations on cancer prevention, control and survivorship (CaPCaS). This goal will be achieved through three
specific aims:
(1)
Using the MCCCC Cancer Advocacy Handbook, train 15 (5 at each site) cancer
advocates/survivors to lead the CaPCaS communication campaigns as CHEs, focusing primarily on improving
cancer health and clinical trials literacy, increasing awareness about cancer prevention, screenings and genetic
testing, and promoting preventive lifestyle behaviors; Adapt and implement evidence-based and innovative,
culturally tailored, multi-channel educational communication campaigns tailored to Black men in FL CA,
Hispanics in AZ CA and rural populations in the Midwest/MCHS geographies; and Evaluate the impact of the
CaPCaS campaigns relative to increasing CaPCaS-related knowledge, attitudes, behavioral intention and
adoption of prevention behavior.The academic-community team assembled for this project is comprised of health
equity scientists, behavioral scientists (including implementation science researchers), clinician scientists, and
public health professionals with significant expertise in health communications.
(2)
(3)

Public health relevance
PROJECT NARRATIVE This application is being submitted by the Mayo Clinic Comprehensive Cancer Center (MCCCC) in response to the “Administrative Supplements for the NCI P30 Cancer Center Support Grants for Multi-Channel Communication Campaigns”. The primary goal of the administrative supplement is to assess the impact of multi- channel communication campaigns targeting Black, Hispanic, and Rural populations on cancer prevention, control and survivorship (CaPCaS).